State-dependent modulation of interactions of theta and gamma rhythms in working memory

ABSTRACT
Transcranial alternating current stimulation (tACS) is a noninvasive neuromodulation technique that allows
for frequency-specific entrainment of brain oscillations. Many cognitive functions are underpinned by
oscillatory timing and patterns, and cognitive deficits in neuropsychiatric disorders are associated with
disturbances in those patterns. tACS has the potential to synchronize rhythmic activity and mitigate
cognitive deficits. However, a major challenge is that the effects of tACS on brain oscillations depend on
the current brain state of the individual and on the timing of stimulation relative to the phase of ongoing
oscillations. Using a working memory paradigm, we will address this challenge by investigating the state-
dependent effects of tACS delivered to the left dorsolateral prefrontal cortex (DLPFC) on theta-gamma
cross frequency coupling (tgCFC) and theta fronto-parietal phase synchronization, two EEG markers
critical to working memory function. Specifically, in Aim 1, we will test the hypothesis that tACS with theta-
nested gamma waveform delivered intermittently during key task epochs with strong tgCFC will improve
cross-frequency interactions and frontoparietal phase synchrony during performance of a spatial working
memory task, relative to tACS delivered with the same waveform during task-free epochs and sham
stimulation. In Aim 2, we will test the hypothesis that closed-loop gamma tACS applied in phase with
ongoing theta oscillations will enhance cross-frequency interactions and fronto-parietal phase
synchronization relative to open-loop tACS with theta-nested gamma waveform. We will also determine
the relationship between tACS-induced change in task performance and change in EEG markers across
different stimulation conditions. These studies will help us identify reliable strategies to manipulate cross-
frequency interactions between theta and gamma rhythms and to enhance phase synchronization
between frontal and parietal regions, which support working memory function. They will also lay the
groundwork for potential clinical trials that can test the efficacy of task-locked and closed-loop stimulation
paradigms in clinical populations.

Public health relevance
NARRATIVE In this project, we will use two novel, noninvasive brain stimulation protocols and electroencephalography to modulate and measure brain oscillations that support working memory. Our study will help us to identify reliable strategies to manipulate important biomarkers for working memory. It will also be an important step forward in developing novel ways to improve cognitive function in patients with neuropsychiatric illnesses.